The Affordable Care Act: MCV/PCV & Pertussis

DESCRIPTION (provided by applicant): The Colorado Department of Public Health and Environment proposes activities that will support enhancement of epidemiology and laboratory capacity of its existing Emerging Infections Program (EIP). Specific proposed activities include support of: 1) personnel who have responsibility across multiple EIP activities including an EIP Administrator, FoodNet Coordinator, and EIP Laboratory Coordinator;2) education of EIP collaborating infection preventionists and laboratorians, and attendance at training meetings of EIP staff;3) information technology infrastructure;and 4) influenza (PCR testing) and healthcare-associated infections (bloodstream infections in dialysis facilities) epidemiology and laboratory capacity.

Public health relevance
DUNS #878208826 EMERGING INFECTIONS PROGRAM (EIP) - PPACA ENHANCING EPIDEMIOLGY AND LABORATORY CAPACITY Funding Opportunity Number: RFA-CI-10-003 Submitted August 27, 2010 Communicable Disease Epidemiology Program Disease Control and Environmental Epidemiology Division Colorado Department of Public Health and Environment 4300 Cherry Creek Drive South Denver, CO 80246 PROJECT NARRATIVE RESEARCH PLAN BACKGROUND AND UNDERSTANDING The Colorado Department of Public Health and Environment (CDPHE) is applying for ACA funding through this FOA to support enhancement of epidemiology and laboratory capacity of its existing Emerging Infections Program (EIP). The CDC-funded EIP network of 10 sites conducts: 1) active surveillance; 2) applied public health epidemiologic and laboratory studies; 3) implementation and evaluation of pilot prevention/intervention projects; and 4) flexible response to public health emergencies. Colorado established its EIP in 2000 with the five-county Denver metropolitan area (Adams, Arapahoe, Denver, Douglas, Jefferson counties) as its defined population for active surveillance. The estimated 2009 population (Colorado State Demography Office) of these five counties is 2.5 million persons, approximately 49% of the statewide population of 5.1 million. In 2002, Colorado's FoodNet project expanded its suirveillance area to seven Denver metro counties by adding Boulder and Broomfield counties. The original five county Denver metro area remains the project surveillance area for ABC's (including MRSA), influenza, Clostridium difficile infection, and healthcare-associated infections activities. The Colorado EIP is organizationally part of the Communicable Disease Epidemiology Program (CDEP) within the Disease Control and Epidemiology Division of CDPHE. CDEP has used its existing strong relationships with hospital infection preventionists (IP), clinical laboratories, and local health departments (LHDs) to establish and integrate EIP activities into routine communicable disease reporting, surveillance, and investigation activities. These existing partners incorporated reporting of cases for EIP surveillance (IPs), submission of isolates (clinical labs), and collection of EIP supplemental case information (LHDs - for FoodNet pathogens). Currently, there are 16 clinical labs within the five-county Denver metro ABCs surveillance area (13 hospital- based, 1 staff-model HMO, 2 commercial) with which ABCs conducts active, lab-based surveillance. The 13 hospital-based labs serve 20 hospitals. There are two additional hospital-based clinical labs with which FoodNet conducts active lab-based surveillance in its seven-county Denver metro surveillance area, and there is one additional commercial lab that primarily serves nursing homes and is a primarily a source of C. difficile infection reports. An additional vital partnerships was formed initially with the University of Colorado Health Sciences Center-Department of Preventive Medicine, now the Colorado School of Public Health, to contract for MPH students to work on-site with the Colorado EIP. This contract has supplied the Colorado EIP with high quality part-time public health students to help staff especially the influenza, MRSA , and CDI surveillance projects. The students perform chart review and phone interviews as needed for these projects. This flexible model of staffing has worked well for the Colorado EIP and additionally provides a great training opportunity for these public health students. 2 The Colorado EIP has successfully implemented and conducted ABCs (including MRSA), FoodNet, influenza, CDI, and most recently HAI projects including the implementation of active, laboratory-based surveillance, the collection of high quality surveillance data, and the conduct of numerous ABCs, FoodNet, and influenza special epidemiologic studies such as the pneumococcal conjugate vaccine effectiveness studies (initially PCV-7 and currently PCV-13), meningococcal conjugate vaccine effectiveness study, influenza vaccine effectiveness studies (pediatric and adult) the Salmonella Newport/Enteritidis case-control study, the infant Salmonella and Campylobacter case control study, multi-drug resistant Salmonella study, and E. coli O157 cohort study. The Project Director for the Colorado EIP is Ken Gershman, MD, MPH (EIS -1989), a CDC-trained public health epidemiologist with over 20 years of public health epidemiology and management experience, who has been Chief of the Communicable Disease Epidemiology Program since 2000. Dr. Gershman is also Project Director for the Epidemiology and Laboratory Capacity for Infectious Diseases (ELC) cooperative agreement. The EIP (and also ELC) Co-Project Director is Hugh Maguire PhD, the state laboratory Microbiology Program Manager, who has over 25 years of experience in the molecular biology of human viruses in both the academic and the private sectors. With the above overlapping project direction for EIP and ELC, Colorado has successfully coordinated and leveraged these two major epidemiology and laboratory cooperative agreements. Dr. Gershman also serves as Project Director for ABCs and influenza EIP activities. The Project Director for FoodNet is Alicia Cronquist, MPH, RN (EIS - 2001), a CDC- trained public health epidemiologist who is the Fooodborne/enteric disease Coordinator within the Communicable Disease Epidemiology Program and is supervised by Dr. Gershman. Ms. Cronquist also has served as FoodNet Coordinator and has been in her current position since 2003. Under the leadership of Ms. Cronquist, Colorado FoodNet was recognized for outstanding data quality by the FoodNet Steering Committee in 2010. The new (since 2009) Project Director for Colorado's EIP Healthcare-Associated Infections (HAI) activities is Wendy Bamberg, MD (EIS - 2005), an infectious disease trained physician who did her EIS training in Colorado under the supervision of Dr. Gershman and Ms. Cronquist. Under the direction of Dr. Bamberg, Colorado EIP HAI activities have included: current participation in the Phase II: Healthcare Associated Infections and Antimicrobial Use Prevalence Survey and plans to participate in Phase III of the project; a project to evaluate and validate a simpler method of collecting denominator data through the National Healthcare Safety Network (NHSN) for device-associated infection surveillance; a case-control study to evaluate risk factors for healthcare-associated community onset (HACO) MRSA; and the proposed (in this application) project for surveillance of bloodstream infections in outpatient hemodialysis facilities. Dr. Bamberg also works closely with the Patient Safety Program, located in the Department's Health Facilities Division, which manages data reported through NHSN, to collaborate on project development and to participate in advisory committee meetings for NHSN reporting. 3 The Colorado EIP currently subcontracts with Dr. Connie Price at Denver Health Medical Center on the CDI surveillance project to provide additional technical expertise. Dr. Price serves as the Healthcare Epidemiologist/Medical Director of Infection Control for Denver Health Medical Center and is an Assistant Professor of Medicine at the University of Colorado Health Sciences Center. She has extensive experience in the surveillance, prevention, and control of CDI in the hospital setting. State public health laboratory activities that support the Emerging Infections Program (EIP) are fulfilled by staff assigned to one of three work units: Molecular Science, Public Health Microbiology, and Environmental Microbiology. A long-term goal for the laboratory has been the broader implementation of molecular detection technologies in each work unit. Technical expertise in automated or molecular-based diagnostics has now been translated across all three units at a basal level and needs to be further developed. Even staff with cursory training were enlisted in the response to the Influenza H1N1 pandemic during which over 7,000 respiratory specimens were tested by RT-PCR for the presence of influenza viruses with subtyping on specimens testing positive for influenza A virus. All laboratory test findings are transmitted daily to a data repository that can be queried by the Communicable Disease Epidemiology Program, or by spreadsheets maintained on shared network drives (e.g., influenza PCR results). NEED 1. SUPPORT OF PERSONNEL Support of Personnel - EIP Administration The Colorado EIP Principal Investigator (PI)/Project Director, Dr. Ken Gershman, has also fulfilled the functional role of EIP Administrator for the past 10 years which has consumed much time and effort, limiting Dr.Gershman's available time to provide scientific leadership and participation in the EIP network. The important administrative functions necessary to successfully implement and maintain an EIP site include: coordination of grant preparation and submission; budgeting and budget monitoring; tracking, requesting, and efficient use of unobligated and supplemental funds; staffing and hiring; contract monitoring; and coordination of IRB status, tracking, and renewal of multiple EIP research projects. Having a dedicated EIP Administrator position to handle much of this important, but non-scientific work, would free up the EIP PI to contribute more to the scientific aspects of Colorado's EIP site and the overall EIP network. In this application, Colorado is requesting new funding for one FTE who will assume EIP Administrator duties to enhance the administrative and management aspects of the Colorado EIP, and so that the Colorado EIP PI can participate and contribute more fully to the scientific aspects of EIP network activities. 4 Support of Personnel - FoodNet The Colorado FoodNet Principal Investigator position has functioned as both FoodNet Principal Investigator and FoodNet Coordinator since Colorado joined FoodNet in 2000. During that time Colorado has expanded its activities to include a full range of FoodNet projects, and would like to be able to take a more active role in leading working groups, data analysis, manuscript preparation and project development. Colorado is not currently leading a working group or an analysis and has not met the performance standard of submitting one first-authored abstract to a state or national conference per year. This is largely due to the need for increased staff to assume this new role in FoodNet. The current FoodNet Primary Investigator, Alicia Cronquist, MPH, BSN, receives 50% of her funding from FoodNet; the other 50% of her time is devoted to statewide foodborne disease activities including surveillance, training, and outbreak investigation. In this application, Colorado is requesting new funding for one FTE who will assume FoodNet Coordinator and data management duties, so that Colorado can participate more fully in the full range of FoodNet activities with a FoodNet Principal Investigator and a FoodNet Coordinator, similar to other FoodNet sites. With this new funding and staffing, the FoodNet PI will be able to volunteer to lead a working group, analyze data for a conference abstract or a manuscript, or chair a working group. Support of Personnel - Laboratory Two of the three laboratories that participate in EIP-related activities are understaffed, creating a gap affecting any transition from routine surveillance to outbreak response. The consequence is that some EIP activities assume higher priority than others during outbreaks. Additional staffing, in conjunction with reassignment of current staff to higher levels of EIP participation, is needed to remedy the situation. A gap between FoodNet activities and resources to support molecular-based testing continues to expand. Established testing algorithms rely heavily upon polymerase chain reaction (PCR) technology to provide direction to rapidly evolving public health events. This need is evident in FoodNet activities and Influenza surveillance. Additional lab staff require training to support PCR, PFGE, MLVA, and DNA sequencing. While specimen volume for Influenza testing is not expected to approach that of the previous (H1N1 pandemic) season, adequate surveillance will require a higher level of commitment of laboratory resources. Reagents to perform both primary screening and strain typing of Influenza A- positive specimen will still be available through the Influenza Reagent Resource (IRR) as needed; however, the disposable supplies needed to support high volume testing must be procured in advance to ensure sustained, real-time identification and strain typing throughout the season. In this application, Colorado is requesting new funding for 0.4 FTE who will assume EIP Lab Coordinator duties, as well as increased EIP funding of multiple other laboratory staff to dedicate more of their time to EIP activities. 2. EDUCATION/TRAINING 5 There is a need to support the education and training of hospital infection preventionists and laboratorians without whom EIP active, laboratory-based surveillance could not be conducted and maintained. In addition, more is constantly being asked by EIP of these collaborators whose EIP-related efforts are not reimbursed and who have more than full workloads related to their primary hospital/laboratory duties. 3. INFORMATION TECHNOLOGY Both ABCs and FoodNet projects have ongoing modifications (additions, revisions, deletions) to the data collected that require the CEDRS (used by Colorado as its ABCs and FoodNet "database") programmer to develop or modify code to capture the data and to extract and transmit these data to CDC. ABCs and FoodNet could not be successfully implemented and maintained (including providing data to CDC) without the support of Colorado's CEDRS programmer/administrator, yet CDC has not previously funded this vital position. 4. INFLUENZA & HAI EPIDEMIOLGY/LABORATORY CAPACITY For the upcoming 2010-2011 influenza season, which is the first post-H1N1pandemic season, there is a need to continue RT-PCR typing and sub-typing of influenza positive respiratory specimens to support high quality surveillance for influenza hospitalizations and the conduct of the influenza vaccine effectiveness study. There is also a need to better understand the morbidity and mortality burden of seasonal influenza using methods (i.e., "pyramid" multiplier model) developed by CDC during the H1N1 pandemic. As hemodialysis centers begin to track bloodstream infections (BSIs) as part of improving quality of healthcare, and, in Colorado, as part of mandatory reporting, there is a need to simplify and minimize the burden of detecting and reporting useful metrics. By participating in this project, Colorado EIP will help evaluate and validate proposed reporting metrics for BSIs among outpatient hemodialysis facilities using existing electronic laboratory and health record data. Due to mandatory reporting of these infections in Colorado, Colorado EIP has a particular interest in evaluating methods to simplify the reporting process and evaluate standardized case finding approaches. Of 65 dialysis units in the state of Colorado, 29 of these are outpatient hemodialysis facilities in the 5-county Denver metropolitan EIP catchment area. The majority of these facilities are either DaVita (n=18) or Fresenius (n=4) facilities. 6 OPERATIONAL PLAN The objectives and activities proposed below represent enhancements to the basic epidemiology and laboratory infrastructure of the Colorado EIP, so that it can remain flexible and able to implement and conduct an increasing array of complex EIP projects. ACTIVITY 1 - Support of Personnel A. EIP Administration Colorado EIP is requesting 1.0 FTE to serve as EIP Administrator. The EIP Administrator will be trained directly by the EIP PI, Dr. Ken Gershman, who has performed both PI and administrator roles for 10 years. Objective 1A: Hire an EIP Administrator and implement separate EIP PI and Administrator positions to enhance productivity and scientific participation in EIP Activities by September 29, 2011. Plan: The EIP Administrator position will be recruited and hired through the department's competitive hiring process to ensure the best pool of high quality candidates. This process will take approximately three months. The EIP Administrator will be primarily trained directly by the EIP PI (Dr. Ken Gershman), with assistance from the FoodNet PI (Alicia Cronquist). The EIP Administrator will have the following duties: " Coordination/preparation and submission of new and continuation grant applications, supplemental and unobligated requests, requests to remove funding restrictions " Preparation and monitoring of budgets including planning/use of unobligated funds " Preparation and monitoring of contracts with local health departments and Colorado School of Public Health " Monitoring and planning staffing for multiple (and changing numbers of) EIP projects " Announcing and recruiting new positions and vacant positions " Coordination, tracking, and renewal of IRB submissions Timeline: If funds are awarded, we will recruit and hire a new staff member to fill this position as soon as possible. Because of required Human Resources processes in the state, this will likely take 3 months from date we are notified of the award. However, once hired, training can be rapid based on efficient transfer of skills and information, and hands-on training by the EIP PI and FoodNet PI. B. FoodNet Colorado EIP is requesting 1.0 FTE to serve as FoodNet Coordinator, similar to other FoodNet sites. The FoodNet coordinator will be trained directly by the Foodnet PI, Ms. 7 Alicia Cronquist, who has performed both PI and coordinator roles for 8 years. The FoodNet PI will oversee all FoodNet activities and projects and will directly supervise the FoodNet Coordinator and the three (partially FoodNet-funded) FoodNet Surveillance Officers (SO's) Colorado is an active participant in a variety of working groups and analytic subgroups, but is not currently leading a working group or an analysis. Colorado is not currently meeting the performance standard related to leadership in FoodNet. This is largely due to the need for increased staff to assume this new role in FoodNet. Objective 1B: Hire a FoodNet Coordinator and implement separate FoodNet PI and Coordinator positions to enhance productivity and participation in FoodNet projects and working groups by September 29, 2011. Plan: The FoodNet coordinator position will be recruited and hired through the department's competitive hiring process to ensure the best pool of high quality candidates. This process will take approximately three months. The FoodNet coordinator will be trained directly by the Foodnet PI (Ms. Alicia Cronquist), who has performed both PI and coordinator roles for the past 8 years. The FoodNet Coordinator will have the following duties: " Day-to-day management of FoodNet data o Review data weekly to ensure case definitions are met o Review data for quality/completeness o Provide feedback and quarterly exception reports to local public health departments to facilitate data cleaning and completeness o Train local health department staff on FoodNet protocols and coordinate the monthly FoodNet meeting with participating FoodNet counties o Transmit surveillance data to CDC in the required format " Participate actively in developing or modifying FoodNet surveillance protocols, as appropriate, and participate in FoodNet Coordinator working group calls. o Coordinate collection of Campylobacter exposure data in core FoodNet surveillance data o Coordinate collection of data for non-cultured confirmed 'cases' in FoodNet data and ensure those data are transmitted in the main FoodNet dataset to CDC " Collaborate with the CEDRS programmer to implement database changes as necessitated by FoodNet protocol changes; test the data to assure data quality " Assure lab audits are being completed per FoodNet protocol " Attend the annual FoodNet Coordinators' meeting " Monitor IRB review status for all protocols and coordinate submissions to the CDPHE IRB in a more timely manner " Analyze Colorado surveillance data and produce annual reports and multi-year data summaries for FoodNet pathogens to be posted on CDPHE website and disseminated to local public health agencies and health care providers 8 " Collaborate with laboratory staff to ensure quarterly NARMS submissions and outbreak isolate submissions are timely and data sent with isolates are complete and accurate Timeline: If funds are awarded, we will recruit and hire a new staff member to fill this position as soon as possible. Because of required Human Resources processes in the state, this will likely take 3 months from date we are notified of the award. However, once hired, training can be rapid, as Colorado is very proficient in data management processes, has been performing FoodNet surveillance for 10 years, and has several experienced staff members, including the FoodNet PI. Further, one requirement for the position would be SAS, data management skills and at least one year of experience, so the Coordinator would be expected to be able to 'hit the ground running.' Within one month of being hired, the FoodNet Coordinator, will have met with each local health department and learned the basic processes of FoodNet surveillance from the FoodNet PI. Within 2 months, the FoodNet Coordinator will be independent in data cleaning and sending exception reports to local health departments. Within 3 months of hire, the FoodNet Coordinator will be proficient with monitoring IRB review schedules, and will be independent with FoodNet data transmissions and coordination of monthly FoodNet meetings. The FoodNet Coordinator will participate in annual data cleaning for closeout during spring 2011. C. Laboratory Objective 1C.1: Hire an EIP Laboratory Coordinator to enhance timeliness and completeness of EIP isolate submission to CDC by September 29, 2011. Plan: To address staffing shortages that impact EIP activities, a new EIP Laboratory Coordinator position will be created to oversee all aspects of microbial isolate documentation and referral. This position will ensure prompt acquisition, confirmation, and submission to CDC of ABCs, NARMS, MRSA, and C. difficile isolates. The position will be filled by an experienced microbiologist with medical technology certification. Specific tasks are as follows: " Coordinate EIP microbial isolate documentation and referral to CDC " Insure timeliness of EIP isolate submission to CDC " Provide packaging and shipping training to all staff assigned to EIP activities Objective 1C.2: Increase EIP funding of selected key state laboratory staff to enhance timeliness and completeness of EIP funded laboratory activities and increase molecular testing capabilities by September 29, 2011. Plan: To address other staffing shortages that impact EIP activities, targeted reallocation of current staff to EIP activities will be implemented with the intention of improving efficiency at all points of the laboratory process from sample accessioning through data transmission. Intensive training will be delivered as needed to increase the molecular 9 diagnostic capabilities of all work units assigned to EIP activities. Increased staff numbers will be dedicated to support enhanced molecular testing of FoodNet and Influenza specimens. Specific tasks are as follows: " Increase the number of staff capable of performing molecular diagnostic testing " Utilize Influenza Reagent Resources to expand surveillance in this area to include screening, identification and subtyping relative to typical respiratory season levels " Train one additional staff member to perform MLVA and DNA sequencing " Refine the laboratory information system to capture all molecular testing and connect to population of shared databases for real-time results reporting ACTIVITY 2 - Education and Training A. Education of Infection Preventionists and Laboratorians Objective 2A: Purchase and distribute educational guidebooks to EIP partners - infection preventionists and laboratorians, by December 31, 2010 Plan: Appropriate epidemiology and laboratory guidebooks that would contribute to the education of EIP-collaborating infection preventionists (IPs) and laboratorians have been identified through discussions with members of these groups. The identified guidebooks are: Practical Healthcare Epidemiology, 3rd ed. The University of Chicago Press, 2010; and Color Atlas of Medical Bacteriology, ASM Press, 2004, respectively. These books will be ordered by program support staff during early October 2010 and distributed to our EIP partners by EIP surveillance officers before the end of calendar year 2010. B. Training of EIP Staff Objective 2B: Support travel of EIP staff to attend meetings and conferences of EIP training value by September 29, 2011. Plan: Funding is being requested to support travel of EIP epidemiologists and state laboratory staff to attend EIP-related meetings and professional conferences that will contribute to relevant education and training for EIP activities. Requested travel includes: y 1 trip to 2011 FoodNet Vision meeting for CDPHE laboratory scientist y 1 trip to 2011 FoodNet Coordinator Meeting for new FoodNet Coordinator y 1 trip to national PulseNet Update meeting for CDPHE laboratory scientist y 1 trip to APHL annual meeting for CDPHE laboratory scientist ACTIVITY 3 - Information Technology Objective 3A: Collaborate with CDC on the development and management of interoperable EIP information systems by September 29, 2011. Plan: Colorado EIP will collaborate with CDC on the development, implementation and management of standard and interoperable information systems to be used across EIP 10 activities. The CEDRS (web-based disease reporting system used for ABCs and FoodNet data) programmer/administrator, Mr Larry Loveland, will lead these efforts for Colorado and work with CDC programmers and database managers. Objective 3B: Support varied and changing data collection and transmission to CDC for multiple EIP projects through September 29, 2011. Plan: During 2010-11, the CEDRS programmer/administrator (Larry Loveland) will: y modify CEDRS (Colorado's ABCs "database") fields according to revisions in the ABCs case report form and modify (and test) the data export program to incorporate new/revised fields into ABCs data transmissions to CDC y add fields to CEDRS (Colorado's FoodNet "database") to allow capture of more exposure data for Campylobacter cases and modify (and test) the data export program to incorporate those new fields into FoodNet data transmissions to CDC y develop and test code to export 'deleted' FoodNet cases in CEDRS (i.e. those that do not meet case definitions) so they can be incorporated more or less seamlessly into the main FoodNet dataset sent to CDC, for purpose of tracking non-culture confirmed cases. ACTIVITY 4 - Influenza and HAI Capacity A. Influenza Objective 4A.1: Conduct influenza rRT-PCR testing to type and subtype specimens from laboratory-confirmed hospitalized cases of influenza to support EIP influenza surveillance and vaccine effectiveness studies through the 2010-2011 flu season. Plan: A sample of respiratory specimens from hospitalized influenza cases from EIP- Influenza surveillance area hospital labs (n=13) will be requested for submission to the state public health laboratory for influenza typing and subtyping by rRT-PCR. To maximize efficiency of resources and the testing process, the requested sample will be derived only from specimens testing positive by rapid influenza tests at EIP hospitals. The proposed sampling scheme will most likely involve asking that each of the 13 EIP hospital labs submit up to the first 15 rapid test positive specimens each month during the 2010-2011 influenza season. Depending on the relative severity of the 2010-2011 flu season, this should result in 250-750 confirmed positive specimens with typing and subtyping results. Ms. Deborah Aragon, the current EIP flu (and ABCs) activities coordinator will implement this activity prior to the beginning of the 2010-2011 flu season; however, funding is being requested to support 1.0 FTE of a new epidemiologist who can assume the EIP flu coordinator role as these activities have increased in number and scope. Objective 4A.2: Adapt and implement the "2009 H1N1 pyramid multiplier model" to estimate seasonal influenza burden in Colorado by September 29, 2011. Plan: Colorado's EIP-Flu PI (Dr. Ken Gershman) will participate in the development of a standard protocol to be used across EIP sites which uses a "pyramid" multiplier model to estimate the numbers of cases, hospitalizations, and deaths due to seasonal influenza. As part of this standard protocol, Colorado EIP will assess the following: 11 y Determine the incidence of pneumonia and influenza in hospitalized persons using hospital discharge data y Determine the proportion of hospitalized patients with pneumonia and ILI tested for influenza, and the types of tests used y Determine the number and age distribution of deaths with lab-confirmed influenza in the catchment area y Determine the incidence of ILI in the surveillance area using either ILI surveillance data or BRFSS data, and the proportion tested for influenza Ms. Deborah Aragon, the current EIP flu (and ABCs) activities coordinator will initially implement this activity during the 2010-2011 flu season; however, funding is being requested to support 1.0 FTE of a new epidemiologist who can assume the EIP flu coordinator role as these activities have increased in number and scope. B. Healthcare-Associated Infections Objective 4B: Determine the feasibility and validity of laboratory-based surveillance for BSIs in outpatient hemodialysis patients by September 29, 2011. Plan: The objective of this project is to determine the feasibility and validity of laboratory-based surveillance for BSIs in outpatient hemodialysis patients using electronic data obtained from national chain dialysis facilities, data reported through NHSN, and medical record review. This project will inform and drive the case finding approach to BSIs in dialysis patients to use in dialysis centers nationwide, with the overall objectives of describing the epidemiology of BSIs among hemodialysis patients and assessing risk factors and preventability of BSIs in this population. Colorado EIP has been collaborating with CDC to develop a common protocol for this project, and will continue to participate in the writing and review of the common protocol. The timeline for this project will be determined by this common protocol. There are 22 outpatient DaVita (n=18) and Fresenius (n=4) hemodialysis facilities in the EIP catchment area; Colorado EIP plans to recruit these 22 facilities to participate in this project. If the common protocol includes facilities other than DaVita and Fresenius, Colorado EIP will plan to recruit these facilities as well. Colorado EIP will work with recruited facilities to determine the location of blood culture testing and hospitalization for patients treated at these centers and will conduct site visits to meet staff and determine the best access to patient records. Colorado EIP is also in the process of adding HAIs in the five-county EIP surveillance area to the reportable conditions list, and has already received approval from the Colorado Board of Health to schedule a rulemaking hearing (i.e., a vote) in November 2010. If approved by the Board of Health (fully anticipated), data collection for this project will fall under the Department's surveillance authority and IRB approvals will not be needed. Colorado EIP will implement a standardized case finding approach using existing electronic laboratory and health record data obtained by CDC from DaVita and Fresenius, receive electronic line lists of potential BSIs and revi...